COMPARISON OF MINIMAL MODEL VS EUGLYCEMIC INSULIN CLAMP IN NIDDM

The aim of this work is to compare the minimal model and the euglycemic hyperinsulinemic clamp techniques as methods of assessment of insulin sensitivity in patients with non-insulin-dependent diabetes mellitus.